3D in vitro model of skeletal muscle development using stiffening silk biomaterials

Hydrogels incorporating silk protein primed with bioactive peptides have been successfully used
to study the cellular processes underlying differentiation of skeletal muscle. However, previous
systems were limited due to their static nature – their mechanical properties are fixed. Recently,
we demonstrated a new silk hydrogel crosslinked with tyramine-substituted silk fibroin that
stiffened over time at controllable rates. The programmable stiffness of these hydrogels makes
them attractive for modeling the changes in tissue-level stiffness that are associated with
musculoskeletal development, or following injury. We will modify these hydrogels to incorporate
decellularized muscle extracellular matrix (ECM), obtained through a recently established
decellularization protocol. Our preliminary data suggest coupling ECM to our silk matrices can
be used to further fine-tune the stiffening, enabling highly controllable and distinct mechanical
and matrix protein gradients within the same gel, by spatially varying the amount and type of
ECM mixed in with the silk precursors. A silk-ECM hydrogel has not previously been developed.
Our central hypothesis is that dynamically stiffening hydrogels with highly tunable mechanical
and biochemical characteristics can recapitulate key aspects of the myogenic environment more
effectively than existing engineered systems, and as a result, will improve our understanding of
the process to enable better control of the therapeutic potential of myogenically differentiating
iPSCs for regenerating skeletal muscle. We will develop hydrogels as novel in vitro systems to
explore the impacts of dynamic stiffness on myogenesis of iPSCs. We will test our hypothesis
using two specific aims. The first aim will be to determine how evolving stiffness in 3D hydrogels
impacts iPSC myogenesis. The second aim will be to develop a biochemically functionalized
and mechanically dynamic silk-ECM hydrogel for generation of skeletal muscle from iPSCs.
Completion of these aims will enhance our understanding of the regulators of skeletal muscle
development and the impact of dynamic substrate stiffness and matrix composition on stem cell
differentiation, with the ultimate goal of therapeutically targeting these mechanisms to
regenerate skeletal muscle using stem cells. 3D hydrogels can be further used to investigate
the processes that regulate development, aging, injury, and disease of skeletal muscle.